Confirmatory Safety and Efficacy Trial of Magnetic Seizure Therapy for Depression

Project Summary/Abstract
The goal of this study is to conduct a two-site, double-masked, randomized, non-inferiority clinical trial through
an experimental therapeutics approach to develop magnetic seizure therapy (MST) as a useful and safe
treatment for treatment resistant depression (TRD). In this study, we propose to compare the efficacy of MST
to right unilateral ultrabrief pulse electroconvulsive therapy (RUL-UB-ECT) in regards to suicidal ideation,
depressive symptoms, and cognitive adverse effects in 260 patients with TRD. Importantly, for these two
convulsive therapies, we will identify the neurophysiological targets corresponding with suicidal ideation
reduction and cognitive adverse effects.
ECT is a well-established treatment for TRD, but in Canada and the United States, less than 1% of patients
with TRD receive ECT mainly due to its cognitive adverse effects (i.e., amnesia). Thus, new treatment
alternatives for TRD are urgently needed. One such treatment is MST. MST involves applying a train of high
frequency magnetic stimuli to induce a seizure (compared with ECT that involves applying a train of high
frequency electrical stimuli to induce a seizure). Our pilot data demonstrated that MST can achieve efficacy
that is comparable to ECT but with negligible cognitive adverse effects.
Understanding the neurobiology of TRD, with an emphasis on suicidal ideation, can help accelerate treatment
development. In this proposal, we will evaluate the rates of remission of suicidal ideation of MST compared to
ECT and evaluate whether change in CI from the dorsolateral prefrontal cortex using combined transcranial
magnetic stimulation and electroencephalography is associated with remission of suicidal ideation. We will also
determine the cognitive adverse effects and their neurophysiological targets following a course of ECT in
patients with TRD through electroencephalography.
Positive results from this trial may have tremendous and immediate impact for patients with TRD. First, if MST
demonstrates comparable treatment efficacy to ECT, but with fewer neurocognitive side effects, it could rapidly
be adopted into clinical practice. Indeed, given that the administration of MST is nearly identical to ECT, all
ECT facilities in North America would be able to readily adopt MST. Second, the absence of neurocognitive
side effects will also lead to improved treatment acceptability. Lastly, by investigating key neurophysiological
mechanisms of these treatments, we hope to derive critical mechanistic information underlying TRD treatment.

Public health relevance
Project Narrative We propose to conduct a clinical trial to develop magnetic seizure therapy (MST) as a useful and safe treatment for treatment resistant depression. In this trial, we will compare the efficacy of MST to electroconvulsive therapy (ECT) in relation to suicidal thinking, cognitive side effects and depressive symptoms in 260 patients with treatment resistant depression. ECT is effective for treatment resistant depression but is associated with significant cognitive side effects, stigma and fear such that only 1 percent of patients with treatment resistant depression are willing to accept this treatment. Therefore, new treatment innovations are needed. MST represents one such key innovation. As part of this trial we will also determine the brain targets that can be used to predict response to these treatments. If successful, the results of this study may lead to new and safer treatments for treatment resistant depression and identify brain targets through which these treatment work.